CORE--GLASSWASHING AND MEDIA PREPARATION

The function of this facility is to provide 1) both routine and specialized laboratory glassware cleaning services to the investigators of the Kimmel Cancer Center. 2) to provide a quality-controlled supply of culture medium; 3) to reduce cost to investigators. Operating this facility as a shared resource obviates the need for each laboratory to commit personnel to glasswashing tasks or media preparation, enabling the Cancer Center to realize significant financial savings.